Path C Rhode Island Produce Safety Program’s Plan to Enhance On-Farm Food Safety and Implement the Produce Safety Rule under Path C

PROJECT SUMMARY
Project Title: Rhode Island Produce Safety Program’s Plan to Enhance On-Farm Food Safety and
Implement the Produce Safety Rule under Path C (Regulatory Band 8 and Education & Inventory Band 8)
Project Description: The Rhode Island Department of Environmental Management– Division of
Agriculture (RIDEM) Produce Safety Program will implement a produce safety regulatory program that
will promote and enhance on-farm food safety in the growing, harvesting, packing and holding of
produce on Rhode Island farms. The RIDEM Produce Safety Program will also work to achieve increased
compliance with the FSMA Produce Safety Rule (PSR). This project focuses on a unified partnership
between FDA, RIDEM and other state agencies to achieve a national integrated food safety system.
RIDEM Produce Safety Program will follow Program Path C as described in FOA PAR-21-174. RIDEM has
the regulatory authority to implement, conduct inspection and enforcement activity through the
adoption of 21 CFR Part 112, by refence into Rhode Island Code of Regulations: 250-40-00-2.
Project Goals: This project will follow a multiyear produce project plan to align RIDEM’s regulatory
produce program with the FDA and other state agencies with the goal of promoting public health. Goals
for this project include – developing a Project Plan will document plans, progress, accomplishments, and
setbacks; an Assessment that provides complete jurisdiction information; ensure personnel, supplies,
training, authority, and agreements for program success; provide opportunities for education, outreach,
and technical assistance on the PSR; establish a complete and accurate inventory of produce
farms; establish a compliance and enforcement program; and capability to systematically detect,
investigate, mitigate, document and analyze produce related incidents.
Expected Outcomes: The partnership between state and federal agencies will produce in enhanced on-
farm food safety and improved implementation of the PSR. The collaboration between agencies
leverages existing and future proficiency, knowledge and resources for continued education and
compliance with the PSR in Rhode Island.
Project Objectives: The RIDEM Produce Safety Program plans to use this federal funding to enhance,
continue or establish the following program objectives under Path C as described in FOA PAR-21-174:
Objective 1 – Program Documentation (Assessment and Planning), Objective 2 – Program
Administration, Objective 3 – Education, Outreach and Technical Assistance, Objective 4 – Farm
Inventory, Objective 5 – Inspection Program, Objective 6 – Compliance and Enforcement Program,
Objective 7 – Produce Related Event Response Planning and Implementation
Budget: Year 1: $400,500 per year. Total for Project Period: $2,002,500 (Year 1 – Year 5).

Public health relevance
PROJECT NARRATIVE The Rhode Island Department of environmental Management – Division of Agriculture project: Rhode Island Produce Safety Program’s Plan to Enhance On-Farm Food Safety and Implement the Produce Safety Rule under Path C (Regulatory Band 8 and Education & Inventory Band 8) will implement a produce safety regulatory program that will promote and enhance on-farm food safety in the growing, harvesting, packing and holding of produce on Rhode Island farms. This project will be a partnership between the state of Rhode Island, FDA and other state agencies will result in increased compliance with the Produce Safety Rule, with the goal of promoting public health and integration into a national Integrated Food Safety System (IFSS).